COBRE: Center for RNA Biology in Health and Disease

Project Abstract:
We propose to establish and build the COBRE Center for RNA Biology in Health and Disease at Brown
University in Providence, Rhode Island. The motivation for this effort is the promise that new developments in
RNA biology will drive a better understanding and treatment of human disease. The recent global pandemic
illustrated the importance of understanding RNA viruses(such as Aim 3.4) and the power of nanoparticle RNA
delivery {like Aim 3.3). In addition, advances in structural mapping of RNAs and a new appreciation of modified
RNAs promise are already driving new models for gene expression and human disease. This proposal seeks
to create a research infrastructure and academic community that is positioned to build on these recent
scientific discoveries. The Brown University biomedical community is an ideal environment to achieve this goal.
Brown has recenUy committed over 12 million dollars to the creation of an RNA Center housed in the newly
renovated CIC technology center. In addition to commitments of equipment for the Research Core, there will
be 6 junior faculty hires offered over the next 5 years to replenish the cohort of junior investigators that
graduate from the COBRE due to obtaining R01 funding.
We will bring cutting edge RNA technologies to the state of Rhode Island and evolve a collaborative service
culture where implementing new RNA methodologies will generate samples for downstream analysis by
existing cores. The long-term goal of the Center is to build an RNA biology infrastructure for the greater Brown
and hospital environments that will benefit the study of human disease across all of Rhode Island. The
objective of this proposal is to establish and build the COBRE Center and support the research activities of
Junior Investigators to ensure their transition to independent R01-funded scientists. There are three Specific
Aims - two related to the establishment of the Center, and one encompassing five Research Projects spanning
experimental and computational RNA research. The specific aims that will allow us to achieve these goals are:
AIM 1. Build the Administrative Core that will establish and support the COBRE Center for RNA biology of
human health.
AIM 2. Build the RNome Core that will support the research of junior faculty, increase the ability of academic
researchers to incorporate cutting edge RNA techniques into their research and educate the scientific
community of Rhode Island.
AIM 3. Build the initial cohort of RPLs with complementary backgrounds in biophysics, chemistry,
computational biology and infectious disease.

Public health relevance
Project Narrative: In conjunction with the commitment to a significant focus on and investment in research on the intersection of RNA biology and human health by the Brown University Division of Biology and Medicine, this proposed COBRE Center for RNA Biology in Health and Disease (CRBHD) will provide the support and infrastructure for a new RNome Core Facility that encourages and facilitates collaboration among five well-trained junior investigators with overlapping interests. We will leverage institutional support for the purchase of equipment and prioritization of staff and faculty hiring to lay the foundation for a central resource for RNA research at Brown and in the state of Rhode Island, launching Brown as a national leader in the field. With coordinated training and mentorship, the CRBHD will foster collaborations and create a pipeline of new and seasoned investigators to expand and support a productive community of RNA researchers.